Preclinical and early clinical development of a GABA-A a5 PAM

The overall objective of this UO1 application is to advance the development of BPN-27473, a potent, selective
and orally active GABA-A α5 Positive Allosteric Modulator (PAM) for the treatment of Mild Cognitive Impairment
due to Alzheimer’s Disease (MCI due to AD). As yet, no treatment has shown significant and reliable
therapeutic efficacy on the progression of AD in patients making this an area of extremely high unmet need.
There is strong support from preclinical AD models and human patients, particularly in this early stage of AD,
that neuronal circuits in the hippocampus become excessively active contributing to neuronal pathology and
brain dysfunction. AgeneBio’s GABA-A α5 PAM program represents a novel approach to addressing the
excess hippocampal activity in this patient population at high risk for dementia.
The concept that reduction of hippocampal overactivity is therapeutically beneficial is supported by recent
preclinical and clinical studies using the atypical antiepileptic levetiracetam. Ranging from research on age-
associated memory impairment in rodents to clinical studies in patients with amnestic MCI, beneficial effects on
key circuits in the medial temporal lobe/hippocampus and on memory performance have been demonstrated
by treatment at low doses of levetiracetam that reduce hippocampal overactivity. The strong hippocampal
localization of GABA-A α5 receptors coupled with its role to control tonic inhibition make GABA-A α5 PAMs well
suited to reduce the excess hippocampal activity in MCI due to AD.
BPN-27473 has been well characterized and is a potent, highly selective and orally active GABA-A α5 PAM
that meets discovery in vitro and in vivo criteria. BPN-27473 shows good in vivo receptor occupancy and
studies in rats with age-associated memory loss (a model which shows hippocampal overactivity) demonstrate
that BPN-27473 is effective on improving memory performance after both acute and chronic administration. A
rat dose-range finding study has shown that doses > 15-fold the MED do not have limiting safety or toxicity
liabilities. A suitable scaleup process to enable manufacture large quantities of material has been
demonstrated. The current proposal will expand both non-GMP and GMP scale up of BPN-27473 manufacture
to enable sufficient supplies for the completion IND-enabling safety studies in rats and dogs/monkeys.
Formulation and drug product development will be completed to have a suitable dosage form for Phase I
studies. A pre-IND meeting will be requested from the FDA and the IND will be submitted. A Phase 1 single
ascending dose study in healthy elderly volunteers will be completed. These studies will enable a thorough
understanding of the safety and tolerability of BPN-27473 and its utility for further clinical development.

Public health relevance
The GABA-A α5 Positive Allosteric Modulator (PAM) program represents a novel approach to Mild Cognitive Impairment due to Alzheimer’s Disease (MCI due to AD), a patient population at high risk for dementia and, as such, would address a critical unmet need that will otherwise signiﬁcantly burden patients, caregivers and the healthcare system in the decades ahead. With no current treatments for this indication, it is critical that novel Discovery and Development Programs, such as the one described in this application, advance novel chemical entities (NCEs) at therapeutically relevant targets as rapidly as possible. The GABA-A α5 PAM program beneﬁts from clinical and regulatory paths in place for MCI due to AD along with appropriate mechanistic and therapeutic biomarkers making this a program that can advance the goals of the National Plan to Address Alzheimer’s Disease.